Modeling and Modulating Mechanisms of Escape, Avoidance, and Approach in the Anxiety Disorder Spectrum

PROJECT ABSTRACT
The proposed K23 Mentored Patient-Oriented Research Career Development Award launches a line of work
aiming to comprehensively target mechanisms of avoidance in anxiety and other disorders; and, it provides Dr.
Christopher Sege with skills necessary to becoming a leading clinical researcher. Dr. Sege’s primary clinical
research career goal is to use cutting-edge translational science to improve mental health care by targeting
precise disorder mechanisms. Need for this research is significant and consistent with NIMH priorities and the
RDoC framework. Avoidance is a core target of anxiety and related disorder treatment, but avoidant behaviors
often persist after symptom reduction and keep many from engaging in treatment at all. Novel methods to
target multiple motive drivers of avoidance early in treatment are needed to improve retention and outcome
especially for the 20% of individuals who do not benefit from and 40% who do not complete treatment. Basic
science provides critical clues as to the multiple mechanisms of real-world avoidance that may be indirectly or
inadequately addressed by current treatment techniques. Crucial goals of work proposed here is to determine
how these mechanisms drive clinical behavior and support subsequent work that develops direct intervention
tools. The proposed project uses direct neurostimulation (repetitive transcranial magnetic stimulation; rTMS) in
concert with precise experimental methods to test how specific reactive (escape) and proactive (avoidance)
coping neurocircuits can be modulated to alter downstream fear and approach-avoid decision-making.
Subsequent R-level applications build on this work to determine coping profiles of treatment completers versus
non-completers, and to test how profiles can be more precisely targeted to improve outcomes. A team of
expert mentors (George, Liu, McTeague, Mobbs, Uhde) will use their extensive knowledge in research-based
and clinical neurostimulation, advanced fMRI analysis and research methods, and creation of translational
science-informed treatment adjuvants to support Dr. Sege in his development. Mentorship, hands-on research
tutorials, coursework, seminars/ workshops, and international conference attendance afforded by the K23 will
ensure that Dr. Sege achieves his career goals to: 1) develop expertise in cutting-edge neurostimulation for
research and clinical use, 2) develop expertise in fMRI analysis and research tools for use in concert with
rTMS to more precisely target ecologically-relevant avoidance behavior, and; 3) develop expertise in creating
adjuvants that improve cognitive behavior therapy outcomes through application of translational science. The
proposed K23 will also foster development in areas of publication, grant writing, and inter-departmental
collaboration, all at an institution – the Medical University of South Carolina – which has a strong track record
and commitment to early stage investigators. Proposed K23 activities will prepare Dr. Sege to become a
cutting-edge clinical researcher and a leader in the development of a precision medicine of psychiatry.

Public health relevance
PROJECT NARRATIVE Anxiety and related disorders remain prevalent and costly, and although effective treatments exist, many who suffer with these disorders cannot complete or do not benefit from treatment. Research initiated here seeks to more effectively target, with non-invasive brain stimulation, pervasive avoidance of day-to-day activities, a key disorder feature that keeps many from fully engaging in treatment or attaining symptom remission. Since major depression, substance misuse, and various other mental health disorders also involve pervasive avoidance as a key feature, proposed research could have implications far beyond the anxiety spectrum of disorders.